CHEMOTHERAPY VS RADIATION THERAPY FOR INOPERABLE NONSMALL CELL LUNG CANCER

This study will compare the overall survival, severity, and distribution of toxicities associated with each of the treatment regimens. Patients will be randomized to either arm 1: chemotherapy prior to and during seven weeks of radiation therapy or arm 2: patients will start chemotherapy with radiation therapy. (RTOG 92-04)